A novel molecular determinant of the cardiac beta1-adrenergic receptor response

PROJECT SUMMARY/ABSTRACT β1-adrenergic receptors (β1ARs) are the principle mediators of catecholamine actions in cardiomyocytes. β1ARs rapidly adjust cardiac output by activating a Gs-adenylyl cyclase pathway that increases cAMP, activates protein kinase A, and phosphorylates substrates involved in excitation-contraction coupling. However, chronic β1AR activation in the setting of heart failure leads to a spectrum of changes that contribute to adverse cardiac remodeling. This has been attributed to β1AR activation of signaling pathways that induce cell death. While β1ARs also activate signaling pathway that promote cell survival, this is not sufficient to afford cardioprotection in the setting of heart failure. The notion that β1AR might contain specific molecular determinants that influence their signaling phenotype in cardiomyocytes (and influence the balance of signaling between pro-apoptotic vs. anti-apoptotic pathways) has never been considered. This application implicates the β1AR extracellular N-terminus (which typically is dismissed as playing a negligible role in receptor activation/regulation mechanisms) as a heretofore-unrecognized structural determinant of β1AR activation. We show that the β1AR N-terminus is a target for O-glycosylation at two specific sites (S37/S41) adjacent to an N- terminal cleavage site, that O-glycosylation at these sites prevents β1AR N-terminal cleavage, and that cleavage influences β1AR signaling bias to cAMP/PKA vs. ERK pathways in cardiomyocytes. Studies in aim #1 of the application will take advantage of mutagenesis approaches (generating O-glycosylation-defective, truncated, and cleavage-resistant forms of the β1AR) and a range of state-of-the-art cell-based approaches in cardiomyocytes (including studies with fluorescent sensors) to define the molecular basis for the altered signaling properties of O-glycosylation-defective/truncated β1ARs in cardiomyocytes. The studies will focus on whether the N-terminus exerts its function as an inherent modifier of the β1AR structure itself or whether the altered signaling phenotype of N-terminally truncated β1ARs is due to changes in its subcellular trafficking/compartmentation pattern and/or coupling to signaling partners and downstream effectors. Aim #2 will use mouse models engineered to express mutant glycosylation defective/truncated or cleavage-resistant β1ARs in place of the WT-β1AR, to determine the role of β1AR N-terminal processing as regulator of cardiac function and catecholamine responsiveness. The overarching goal of these studies is to examine the role of the N-terminus as a novel structural determinant of the β1AR that influences signaling to the proarrhythmic cAMP/PKA pathway, contributes to the pathologic cardiac remodeling, and can be pharmacologically targeted to prevent or mitigate the evolution of catecholamine-induced pathologic cardiac remodeling during heart failure.

Public health relevance
PROJECT NARRATIVE β1-adrenergic receptor activation provides short-term hemodynamic support for the failing heart (for example, in the setting of myocardial infarction), but chronic persistent β1-adrenergic receptor activation leads to a spectrum of maladaptive changes that contribute to the evolution of heart failure. The molecular basis for β1- adrenergic receptor-driven maladaptive responses remains controversial and is the focus of this application. We identify a novel structural determinant on the β1-adrenergic receptor that influences β1-adrenergic receptor- driven cellular responses that could be pharmacologically targeted for therapeutic advantage.